The influence of tampon nanoplastic particles on gynecological mucosal barriers

PROJECT SUMMARY
It was recently reported that tampons, a menstrual hygiene product used by over half the population of people
who menstruate, release up to 17 billion nanoplastic particles per use. However, neither the chemical
characteristics of the tampon nanoplastic particles nor the physiological effects of these particles coming in direct
contact with gynecological tissues have been identified. Therefore, the overall goal of this application is to define
both the chemical characteristics of tampon nanoplastic particles as well as their downstream physiological
effects on the gynecological tissue, Typically, the mucosal epithelial barriers of the vagina and cervix serve as
protective barriers against infection and disease, yet there is currently very little known about how nanoplastics
penetrate these barriers, which could potentially induce inflammation, oxidative stress, and dysregulated
hormonal signaling, which cumulatively can lead to cervical and endometrial cancer, vaginosis, endometriosis,
and impaired fertility. Furthermore, there is growing appreciation that exposure to biologically relevant
environments can cause a corona of biological components to form around nanoparticles, altering the surface
morphology and enhancing the internalization of plastic particles. Thus, our overarching hypothesis is that
proteins found in menstrual blood adsorb to the surface of the nano-plastic particles shed from tampons, forming
a biological corona that enables them to penetrate and disrupt cervical and vaginal mucosal membranes. This
hypothesis with be explored by pursuing the following aims: 1. Characterize the surface chemistry of tampon
nanoplastics shed in a biologically relevant environment; and 2. Determine the role of the biological coronas on
tampon nanoplastics' ability to penetrate cervical and vaginal mucosal barriers and detrimentally affect
downstream signaling cascades. The proposed research is significant, because it will provide a comprehensive
overview of the biophysical interactions between tampon nanoplastics, the physiological environment they
encounter, and the gynecological tissue they come in contact with. Absent such insights, people who menstruate
will continue to have insufficient information on the potential detrimental health effects of tampon use.

Public health relevance
PROJECT NARRATIVE People who use tampons are chronically exposing the mucosal barriers of the vagina and cervix to nanoplastics. It is currently unknown if this route of nanoplastic exposure leads to local infection and chronic health problems. Thus, for people who menstruate to make informed decisions about their use of tampons, the physiological effects of these particles coming in direct contact with vaginal and cervical tissue will be identified.